The immunosuppressive function of secretory IgM in tumor-bearing mice

Project Summary/Abstract
Myeloid-derived suppressor cells (MDSCs) exert potent immunosuppressive functions within tumor
microenvironments to promote tumor growth. It is critical to investigate the factors that can upregulate the
functions of MDSCs because such studies can potentially lead to new treatment strategies to suppress the
functions of MDSCs and reactivate the body's immune response to combat cancer. My published data generated
from several tumor mouse models strongly support that secretory IgM (sIgM) produced by normal and leukemic
B cells has strong immunosuppressive functions in inducing the accumulation and upregulating the functions of
MDSCs. To be able to translate my results into a potential therapeutic strategy, I decided to target the synthesis
of sIgM by deleting the function of XBP-1s, because the synthesis of sIgM is tightly regulated by a mechanism
called regulated IRE-1-dependent decay (RIDD), which is hyperactivated in B cells as a response to deficiency
of XBP-1s. Indeed, specific deletion of the XBP-1 gene in leukemic B cells and pharmacological inhibition of
XBP-1s in a B cell leukemia mouse model can lead to downregulated immunosuppressive functions of MDSCs,
supporting the therapeutic potential of targeting XBP-1s in inhibiting MDSCs. These data prompt me to identify
and characterize the mechanisms by which sIgM activates the immunosuppressive functions of MDSCs and to
investigate how to target sIgM to control MDSCs. My goals are summarized in the following Specific Aims: (1)
to identify and characterize the responsible receptors which mediate the immunosuppressive functions of sIgM;
(2) to investigate the downstream molecules that upregulate the immunosuppressive functions of MDSCs upon
stimulation by sIgM; and (3) to test whether deleting the function of XBP-1s from B cells can lead to reduced
growth of solid tumors via suppressing the production of sIgM.
Another main objective of this proposal is to help me initiate and maintain a successful independent research
group to conduct high quality research. To ensure successful completion of this objective, I have identified two
major areas that I will fortify: (1) to enhance my scientific progress through obtaining guidance from my advisory
committee/consultants/collaborators and attending scientific meetings; and (2) to facilitate my career
development through participating in workshops to improve my skills in grant writing, manuscript preparation,
oral presentation, and laboratory management. With protected time and stability provided by the K22 award, I
am confident that I can initiate my own independent research group and successfully compete for R01 funding.
My short-term goals are (1) to secure an independent faculty position; (2) to identify molecular mechanisms that
mediate immunosuppressive functions of sIgM; and (3) to establish new and close collaborations with colleagues
in my future institute. My long-term goals are (1) to develop ongoing projects based on new results obtained; (2)
to obtain independent research grant support (R01); (3) to translate my results into potential new therapies; (4)
to train graduate students and postdoctoral fellows; and (5) to maintain a successful research program.

Public health relevance
Project Narrative Myeloid-derived suppressor cells (MDSCs) play a critical role in suppressing anti-tumor T cell function and promoting tumor progression. The knowledge gained from this research will improve our understanding of the role of secretory IgM (sIgM) produced by normal or cancerous B cells in activating MDSCs to suppress anti- tumor T cell function within tumor microenvironments. Exciting results derived from this study will provide support for targeting sIgM for the treatment of cancer.